Cellular senescence and cell fate/interactions as drivers of Alzheimer's and age-related dementias

OVERALL PROJECT SUMMARY
Aging is by far the most important driver and risk factor for developing a variety of neurodegenerative
diseases, including Alzheimer’s disease (AD) and related dementias. These devastating diseases exact an
enormous emotional, social and economic toll on patients and their families, yet to date there are no effective
treatments that delay, much less reverse, the onset or progression of these diseases. Clearly, new approaches
to understanding and treating age-related neurodegeneration are needed. This Program Project Grant (PPG)
proposal aims to fill this serious gap in our knowledge and treatment approaches. The proposed PPG consists
of three research projects, each focused on an aspect of brain aging that is known to be crucial for brain function:
1) cell fate decisions, particularly cell death and cellular senescence; 2) metabolism, particularly responses
leading to metabolic reprogramming and inflammation; and 3) cell-cell interactions, particularly interactions
between neurons and non-neuronal cells in the brain. We propose to support the projects by an administrative
core, which will also provide statistical and bioinformatics support, and three scientific cores: 1) an
iPSC/Organoid core; 2) a Proteomics and Metabolism core; and 3) a Single Cell and Spatial Transcriptomics
core. The PPG benefits from the exceptionally diverse expertise of the Project and Core leaders and co-leaders,
all of whom are acknowledged leaders in contemporary aging research. Each of the projects is a close
collaboration among several PPG members, many of whom have a history of productive collaboration. Each of
the scientific cores will provide state-of-the art support to the projects, enabling conceptual and technical
advances that would be difficult to achieve in isolation. Together, the Projects and Cores have the potential to
uncover new mechanisms of AD and related dementias, which will be tested in human cells and organoids and
mice. Importantly, these mechanisms can be developed into interventions that can be used treat human patients.

Public health relevance
OVERALL PROJECT NARRATIVE Age is the most important risk factor for developing Alzheimer’s disease and related dementias, but the mechanisms and development of successful treatments remain elusive. We propose to determine how age- related changes in both neurons and non-neuronal brain cells can drive these pathologies, with the long term goal of using these insights into effective interventions.